Understanding Disparities in Genomic Medicine

Project Summary/Abstract
Advances in genomic sequencing and analysis techniques have enabled the molecular diagnosis
of many individuals and families with rare disease. Finding these diagnoses may pave the way to
better treatments or even cures, in addition to decreasing stress and empowering medical
decision-making. However, access to genomic sequencing has not been equitable which has led
to poor understanding of the genomic landscape of rare diseases and of the potential benefit of
genomic medicine in addition to limited insight into factors necessary consider in increasing
access. The Rare Genomes Project (RGP) was established at the Broad Institute in order to
facilitate genetic diagnosis using genome sequencing for individuals and families with rare
disease and has resulted in many diagnoses involving both established and novel disease genes.
Though RGP does allow for more access to genome sequencing than would otherwise be
possible through clinical routes, the RGP study participants have been overwhelmingly white,
well-resourced, and with high educational and household income status. This project seeks to
further expand access to genome sequencing through RGP to historically underserved and/or
minoritized populations in an innovative approach that directly targets barriers identified through
our theoretical framework in order to identify diagnoses for a diverse group of participants with
rare disease (Aim 1). We will also gain critical insight into the process and context of implementing
genomic medicine in underserved populations using outcomes measures derived from our
conceptual framework (Aim 2). Finally, we will also examine motivations for pursuing genome
sequencing and the impact of a genetic diagnosis in underserved/minoritized populations (Aim
3). Taken together, these results will inform future equitable approaches to incorporate genomic
medicine into clinical practice.

Public health relevance
Narrative The promise of genomic medicine has been realized for thousands of individuals with rare disease, with causative variants identified through genomic sequencing that lead to improved clinical and psychosocial outcomes. However, access to genomic medicine and its benefits has not been equitably distributed, and critical questions remain regarding both the optimal implementation of genomic medicine for rare disease diagnosis and its impact. This project aims to expand access to diagnostic genome sequencing to historically underrepresented and underserved populations, which will result in improved understanding of genetic causes of rare disease, motivations for diagnostic genomic sequencing and the psychosocial and health-related impact of a genetic diagnosis, and barriers to implementation of genomic medicine in diverse populations.